Comprehensive elucidation of signaling landscape effects on regulatory T cell phenotype and function

Project Summary
Regulatory T cells (Tregs) play an essential role in maintaining immune homeostasis by preventing autoimmunity,
modulating inflammation, supporting tissue repair, and ensuring balanced immune responses. These functions
are orchestrated by cell-extrinsic signals that drive transcriptional programs necessary for Treg functional
outputs. Recent studies have characterized the effects of various cell-extrinsic signals on Tregs one at a time.
However, due to the diversity, scale, and context-dependent effects of cell-extrinsic signals, comprehensive
understanding of how complex in vivo environmental signals shape Treg functions is lacking. A systematic
understanding of how Tregs interpret cell-extrinsic signals will yield novel insights into basic mechanisms of
immunoregulation, enable precise manipulation of Treg functions in pathological conditions, and inform the
design of novel therapeutic strategies in settings of autoimmune and inflammatory diseases and cancer. This
project aims to comprehensively characterize how cell-extrinsic signals shape Treg functions across distinct
inflammatory environments. In Specific Aim 1, Perturb-seq will be used to, in one pooled experiment, profile
transcriptional changes induced by genetic knockout of hundreds of Treg cell surface receptors in the context of
systemic polytypic (type 1, 2, 3) autoimmunity and tissue inflammation (Aim 1a). Computational analyses of
these data will identify shared and unique transcriptional programs elicited by diverse cell-extrinsic signals and
categorize their functional relevance (Aim 1b). The effects of relevant newly identified signaling pathways on
Tregs will be validated in follow-up experiments (Aim 1c). In Specific Aim 2, the context-dependent effects of
Treg signaling pathways in archetypal inflammatory environments (type 1, 2, and 3) will be explored using mouse
models of airway infections (influenza, Nippostrongylus brasiliensis, Aspergillus fumigatus). We will identify
inflammatory environment driven variation in ligand and receptor expression for novel signaling pathways
identified in Aim 1 (Aim 2a) and generate mice with Treg-specific receptor deficiencies to interrogate context-
dependent effects of signaling pathways on Tregs in these infection models (Aim 2b). Context-dependent effects
on Treg functional outputs will be assessed through analyses of immune responses to infection and tissue
damage in these models (Aim 2c). Overall, this project will leverage innovative high-throughput approaches and
diverse mouse models of infection to comprehensively elucidate how cell-extrinsic signaling environments
influence Treg phenotype and function in context-dependent manners. The depth of understanding provided by
these studies will facilitate development of clinical approaches for precise modulation of Tregs with significant
therapeutic implications. Furthermore, this proposal is tailored to a physician-scientist in training as it focuses on
a cell type with demonstrated clinical relevance and profiles cell-extrinsic signal effects that can be readily
modulated therapeutically.

Public health relevance
Project Narrative Regulatory T cells (Tregs) play an essential role in maintaining immune homeostasis, modulating inflammation, supporting tissue repair, and ensuring balanced immune responses, but comprehensive understanding of how in vivo environmental signals shape Treg functions is lacking due to the diversity, scale, and context-dependent effects of cell-extrinsic signals. This proposal seeks to systematically characterize how cell-extrinsic signals shape Treg functions across distinct inflammatory environments. A comprehensive understanding of how Tregs interpret cell-extrinsic signals will enable precise manipulation of Treg functions in pathological conditions and inform the design of novel therapeutic strategies in settings of autoimmune and inflammatory diseases and cancer.